University of Florida Health Cancer Center Support Grant

OVERALL: ABSTRACT
In recognition of achievements in fostering transdisciplinary research, inclusive workforce development,
community engagement, and ability to enhance its impact on the catchment area (CA), the University of Florida
Health Cancer Center (UFHCC) seeks NCI-Designation. UFHCC is a matrix center that supports cancer
research and career enhancement across all 6 UF health sciences colleges (Dentistry, Medicine, Nursing,
Pharmacy, Public Health & Health Professions, and Veterinary Med) and 5 other UF colleges (Agriculture,
Engineering, Health & Human Performance, Journalism & Communications, and Liberal Arts & Sciences).
Collaborative research is conducted by 147 members across 3 UFHCC scientific programs: Mechanisms of
Oncogenesis, Cancer Therapeutics and Host Response, and Cancer Control and Population Sciences. The
UFHCC provides access to state-of-the-art technologies and research expertise for its members through 3
shared resources: Biostatistics and Quantitative Sciences, Flow Cytometry and Confocal Microscopy, and Next
Generation Sequencing. The UFHCC CA includes 23 contiguous counties in North Central Florida spanning
~17,500 mi2, about the size of Southern New England. Most of the counties (16) are rural and every county is
classified as a Medically Underserved Area. The CA population is 2.2M and includes people who are Black
(16%), Hispanic (10%), and has the highest fraction (23%) of residents ≥65 years in Florida. Through community
outreach, UFHCC supports efforts to increase health literacy, prevention, screening, and research engagement.
The UFHCC Clinical Research Office coordinates all cancer-relevant clinical research at UF, which includes a
state-wide clinical trial network. IITs are facilitated through disease site groups with an IIT Think Tank that fosters
clinician collaboration with basic and population scientists. UFHCC innovations translated to the clinic include
targeted therapies, novel immunotherapies, therapeutic modulation of the microbiome, and new strategies to
communicate with patients. UFHCC Developmental Funds seed early-stage research, support recruitment of
new faculty, and build transdisciplinary teams. UFHCC offers inclusive research career enhancement programs
across the learner spectrum. Since 2016, the UFHCC recruited 58 new members (45 external, 39 early-stage)
(45% women, 17% URM). Peer-reviewed funding increased from $21M in 2016 to $32.6M/yr in 2021 (up 55%);
NCI $9.6M to $13.2M (up 37%). Accruals to all interventional trials rose from 515 in 2016 to 1,748 in 2021 (up
3.4-fold). Institutional support of a $32M/year budget over the next 5 years and 44,000ft2 of new research space
will allow UFHCC to expand. The new UFHCC strategic plan, Momentum 2027, has 4 pillars: 1) conduct
transdisciplinary research (RNA biology, microbiome); 2) translate UFHCC discoveries to trials (immunotherapy,
small molecules, cancer communication); 3) address cancer burden (cancer and aging, cancer health
disparities); and, 4) train a prepared and diverse cancer research workforce, including leadership development.
UFHCC is poised to make a major impact on the cancer burden of the catchment area, Florida, and beyond.

Public health relevance
OVERALL: PROJECT NARRATIVE The mission of the University of Florida Health Cancer Center (UFHCC) is to prevent, detect, and ultimately cure cancer and address the unique challenges of the cancer burden faced by the population we serve by facilitating innovative, collaborative, transdisciplinary cancer research. UFHCC will achieve these goals through discovery and research innovations in cancer mechanisms, prevention, screening, and treatment, while training the next generation of cancer scientists and leaders and engaging the communities and populations we serve.